Role of Cyr61/CCN1 in Mesenchymal Stem Cell Niche and Aging Bone

Aging-related skeletal degeneration is associated with changes in bone microarchitecture, loss of
bone mineral density (BMD), increased susceptibility to fracture, and delayed bone healing. A key
factor in these degenerative changes is the formation of osteoprogenitors (i.e. mesenchymal stem
cells [MSCs]), which decreases with aging and are regulated by cues in the local bone marrow
(BM) microenvironment (niche). To date, the specific changes that occur in the BM niche during
aging are unknown. To address this knowledge gap, Dr. Xiao-Dong Chen's lab developed a
culture system that reproduces the BM-MSC niche ex vivo, used in this project to compare the
growth factor responsiveness of MSCs cultured on ECMs produced by BM stromal cells from
“young” (≤25 y/o) and “old” (≥60 y/o) donors. MSCs on “old” ECM displayed less BMP-2
responsiveness compared to cells on “young” ECM. Recent preliminary data showed that
Cyr61/CCN1, a matricellular protein involved in regulating osteogenesis, was deficient in “old”
compared to “young” ECM and knock-down of Cyr61 in young ECM abrogated BMP-2
responsiveness, confirming the importance of this protein in osteogenesis. Further, treating old
BM stromal cells with adenovirus containing the Cyr61 gene prior to ECM synthesis restored MSC
responsiveness to BMP-2 and studies by Zhao et al (2018) using Cyr61 KO mice (i.e. Cyr61 KO
[yKO]) driven by osterix (Osx) showed that KO mice had reduced BMD relative to wild type (WT).
These findings lead to the hypothesis that aging-related bone degeneration is at least partially
related to depletion of Cyr61 in bone ECM, which negatively impacts the BM niche and reduces
MSC osteogenesis. In the proposed studies, Aim 1 will assess the impact of Cyr61 depletion on
bone phenotype and BM matrix proteome in 3 mo. old (WT-y), 18 mo. old (WT-o) and 3 mo. old
KO (yKO) mice. The bone matrix of WT-o and yKO mice is expected to contain less Cyr61, exhibit
similar aging proteomes, and reduced BMD as compared to WT-y mice. Aim 2 will assess the
ability of ECMs, produced by BM stromal cells from WT-y, WT-o and yKO mice, to support MSC
growth factor responsiveness to BMP-2 and IGF-1 and osteoblast differentiation. These studies
are expected to show that matrix bound Cyr61 determines the ability of an ECM to support MSC
responsiveness to growth factors and osteoblast differentiation. Studies to probe the mechanism
of aging-related changes in Cyr61 are expected to show that higher levels of active YAP [i.e. de-
phosphorylated] in young MSCs promote the expression of Cyr61 and its increased incorporation
into young BM-ECM. In contrast, old MSCs are expected to show lower levels of YAP and reduced
Cyr61 in the ECM. Aim 3 will determine if exogenous rhCyr61 promotes lumbar fusion in WT-o
and yKO mice, either alone or in combination with rhBMP-2. The results are expected to show that
co-administration of rhCyr61 and rhBMP-2 will dramatically improve bone healing, better than
either one alone, especially in WT-o and yKO mice. The results of Aim 3 have high translation
potential as supplementing BMP-2 with Cyr61 will reduce the dose of BMP-2 necessary to achieve
fusion and decrease its side-effects. Overall, the results of this project have the potential to
significantly improve Veteran health care by providing an innovative approach for
regenerating/healing bone under conditions where this is difficult to achieve (i.e. aging-
related diseases and co-morbidities). Moreover, the proposal contains a well-developed plan
for gaining new skills in bone and aging biology, proteomics, bioinformatics, and small animal
surgery and targeted career development to become an independent VA research investigator.

Public health relevance
Aging-related bone degeneration is a major healthcare challenge for America's growing population of aging Veterans. Changes in bone mass and structure occur with age and are common in both women and men, resulting in increased risk for debilitating pain, bone fracture, and delayed healing. With aging, resident stem cells in bone lose their ability to maintain the tissue and bone degeneration takes place over time. My preliminary results suggest that during aging, the level of a protein, Cyr61 (also known as CCN1), becomes depleted in bone. The proposed research will investigate this protein and determine if it's required for normal function of bone-specific stem cells and whether replenishing it during aging restores their function in bone. The results gained from this study may provide a novel approach for reversing bone degeneration during aging or stimulating bone repair after injury.